Clonal hematopoiesis and therapy-emergent myeloid neoplasms in patients with ovarian cancer

ABSTRACT
Most women diagnosed with ovarian cancer are treated with many rounds of chemotherapy and
often years of a an oral PARP inhibitor drug for “maintenance” therapy. These therapies have
extended life for women with metastatic ovarian cancer, but at the cost of increased toxicity.
One long term toxicity is the development of leukemia or other blood disorders, often called
therapy related myeloid neoplasia (TMN). These secondary malignancies are a known risk of
chemotherapy, and ovarian cancer survivors have one of the highest rates of TMN of any group
of cancer survivors. The diagnosis of TMN is usually fatal, with survival measured in months.
TMN is nearly always detectable in a pre-malignant state as a clonal expansion of blood cells
years before a clinical diagnosis. Non-malignant clonal expansion of white blood cells is often
termed clonal hematopoiesis of indeterminate potential (CHIP). The interval between CHIP and
development of blood cancers is many years, providing an opportunity to better understand the
natural progression of TMN and perhaps a window for intervention and prevention. Clonal
hematopoiesis (CH) can also arise during normal aging, but only a small fraction progress to a
blood cancer. A better understanding of the natural progression of CH in ovarian cancer
survivors is needed to tailor safe and effective ovarian cancer therapies. Our team is co-led by
experts in ovarian cancer genetics and hematological malignancies and will enroll 2000
survivors across the country with ovarian cancer, including 200 with CH. We will follow these
individuals with CH with serial blood draws obtained every 6 months for at least 3 years to
define risk factors for progression of CH to TMN. For a subset of patients with acquisition of
TMN during the study, we will evaluate clonal dynamics and genetic and chromosomal
alterations over time at the single cell level, which will provide novel data on the changes that
occur in the malignant transformation of myeloid cells in response to cytotoxic therapy. In this
way, we will learn who is at risk of TMN and develop strategies for the monitoring and
prevention of this deadly long-term treatment toxicity. These studies will improve outcomes for
patients with ovarian cancer and also will be applicable to survivors or many cancer types, who
are also at risk for TMN.

Public health relevance
Project Narrative The goal of this study is to inform the understanding of how therapy related myeloid neoplasia (TMN) develops in women with ovarian cancer in order to develop strategies to monitor and prevent this deadly secondary malignancy. We will enroll and serially follow ovarian cancer survivors with and without clonal hematopoiesis to define risk factors, kinetics, and genetic determinants of progression to TMN.